Winship Cancer Institute Cancer Center Support Grant

PROJECT SUMMARY/ABSTRACT
OVERALL
The mission of Winship Cancer Institute of Emory University (Winship) is to discover cures for cancer and
inspire hope. Winship is the only NCI-designated comprehensive cancer center in Georgia, the eighth most
populous state in the United States, with the second highest Black population in the country, and a growing
Hispanic population. Winship is comprised of 179 members who are national leaders in cancer research, from
31 departments and four schools across Emory University. Winship members form a strong collaborative
research community organized around four research programs supported by nine shared resources. During the
reporting period (2017-2021), members published 2,454 cancer relevant manuscripts (35% collaborative within
Winship and 75% with investigators at outside institutions). Members were supported by a total of $64M in peer-
reviewed cancer-relevant funding and $26.7M non peer-reviewed funding (as of December 31, 2021). Accruals
to interventional treatment trials increased by 23% and to Phase I trials by 34% (2017-2021) compared to the
prior five year time period (2012-2016). Winship has successfully received program project level funding
including a lung cancer SPORE award from the NCI in 2019 (P50CA217691), the myeloma Specialized Center
for Research (SCOR) from the Lymphoma and Leukemia Society in 2020, and a new inter-programmatic P01
for lung cancer research, all targeting high priority cancers in Winship’s catchment area. Research conducted
by Winship has directly contributed to FDA approval of new anti-cancer agents, first-in-human clinical trials, new
NCTN and ETCTN clinical trials (Phase I-III), and health care policy changes in the state of Georgia. Winship’s
strong COE efforts, guided by bi-directional communication with community partners, address several important
themes including tobacco control, HPV vaccination, promoting health literacy, reducing cancer disparities, cancer
screening in individuals living with HIV disease and promoting legislation that impacts the catchment area. Under
the leadership of Executive Director, Suresh Ramalingam, MD, and his senior leadership team, Winship aims
to: (1) conduct transformative research; (2), accelerate the translation of Winship member discoveries, (3) reduce
the burden of cancer in its catchment area, and (4) promote education, training and mentorship. Winship will
pursue these aims through its strong leadership team, robust infrastructure, exceptional institutional commitment,
ongoing community partnerships, and the recently formulated strategic plan for 2022-2026.

Public health relevance
PROJECT NARRATIVE WINSHIP CANCER INSTITUTE OF EMORY UNIVERSITY CANCER CENTER SUPPORT GRANT As the only NCI-designated comprehensive cancer center in Georgia, Winship Cancer Institute of Emory University (Winship) serves as the primary institution for cancer care, research, training, and education for the state. Winship's mission is to discover cures for cancer and inspire hope. Research conducted by Winship has directly contributed to FDA approval of new anti-cancer agents, first-in-human clinical trials, new national clinical trials and health care policy changes in the state of Georgia. Winship aims to: (1) conduct transformative research; (2) accelerate the translation of Winship member discoveries; (3) reduce the burden of cancer in its catchment area; and (4) promote education, training, and mentorship.